Pediatric traumatic brain injury and early life stress effects on prefrontal cortex development and cognition: A role for microglia

Project Summary
Pediatric Traumatic Brain Injury (pTBI) impacts half a million children each year, leaving over 20% with long-
lasting cognitive deficits that negatively impact their quality of life. Children are especially vulnerable to pTBI
because their brains are still developing at the time of injury. A major factor associated with poor outcomes
following pTBI is a life history of early life stress (ELS), such as poverty, abuse, and natural disasters. ELS
increases the risk for pTBI and increases chronic attentional, impulsive, and social deficits. Despite this
established association, the mechanisms underlying how ELS and pTBI generate these neurocognitive
impairments remain poorly understood, leaving these kids with few therapeutic options to improve symptoms.
My laboratory uses lateral fluid percussion injury (LFPI) to model pTBI in rats at postnatal day (P)15, which is
developmentally equivalent to toddler age. Early life injury generates behavioral phenotypes in adult rats that
resemble pTBI symptoms in humans, specifically cognitive alterations and social impairment. Given that
cognitive deficits are the most common lasting symptom of pTBI, this proposal builds upon these findings to
further investigate how pTBI impacts brain development and resulting cognition. I will combine this model with
maternal separation stress and assess development of the medial prefrontal cortex (mPFC), as it is a major
hub for cognitive function. Microglia are the brain’s resident immune cells, regulate brain development,
including synaptic patterning, and are highly sensitive to stress and injury. Thus, microglia may be key to
programming stress and pTBI outcomes. I hypothesize that ELS primes mPFC microglia, enhancing their
response to pTBI, and leading to excessive synaptic pruning in mPFC, reduced structural complexity, and
impaired cognition. The objectives of this proposal are to define acute neuroimmune changes in the mPFC
following ELS+pTBI, determine how these early life insults impact cognitive function in adulthood, and
investigate the association between these acute molecular and chronic behavioral phenotypes. In Specific Aim
1 I will use a) engulfment analysis and Golgi staining to examine microglial pruning and resulting mPFC
neuronal organization, and b) the 5-choice serial reaction time task to assess complex cognitive phenotypes,
including executive function, impulsivity, and attention. In Specific Aim 2 I will use a) transcriptomics to
interrogate the role of microglia in these phenotypes and b) pharmacological intervention to shift microglia
towards a more homeostatic phenotype following pTBI in an attempt to block the development of
neurocognitive deficits later in life. Overall, the findings of these studies will clarify the role of the mPFC and
microglia in ELS and pTBI interactions and provide possible insights into novel treatment options for the long-
term cognitive consequences of these early life insults.

Public health relevance
Project Narrative Pediatric Traumatic Brain Injury is a public health crisis, impacting half a million children a year, having a financial burden of >1 billion dollars annually, and leaving many children with long-lasting cognitive deficits. Despite this, there are few therapeutic options to relieve these symptoms because we still do not know much about how pediatric traumatic brain injury impacts brain development or why some kids experience worse symptoms than others. This innovative proposal combines pediatric traumatic brain injury with early life stress (a known contributor to poor outcomes) to study how these early life insults impact brain development and cognition, targeting microglia cells of the prefrontal cortex.